Segmentation and integration of experience in hippocampal neuronal representations

An episodic memory is a set of moments recalled together; these moments often share a unique combination
of time, location, and content. Despite our experience with memories as falling into these segmented
categories, it is not well-understood how the brain categorizes moments into episodes. It is theorized that the
hippocampus responds to event boundaries in the environment – specific stimuli, changes in location or time,
that trigger movement into the next represented episode. In humans, room boundaries and task changes are
two candidate event boundaries that seem to separate distinct episodes, demonstrated by decreased memory
performance across these boundaries.1 Despite the importance of episodic memory to our everyday
experiences, the neural mechanisms underlying attention to event boundaries is not well understood due to
resolution limitations of fMRI. Rodents provide a window into these potential neural mechanisms of event
boundaries through large scale in vivo electrophysiology recordings of single neurons and local field potentials
(LFP) in the hippocampus. The hippocampus is known to play a role in episodic memory consolidation and
retrieval, as well as in planning and learning. Planning and episodic memory retrieval appear to have similar
mechanisms displayed through replay of place cell sequences representing the track both in moments
preceding and following a run during sharp-wave ripples (SWRs), transient bursts of activity in the 150-250 Hz
LFP band.2 Place cell sequences matching possibilities of the rat's upcoming trajectory also often occur during
theta (5-12Hz) LFP oscillations,3 a phenomenon termed “theta sequences.” Assessing how the brain
represents upcoming runs during theta and SWRs, alongside determining how it replays past runs during
SWRs, together brings us closer to understanding how the brain forms specific episodes. Importantly, reward
locations and environmental changes have been shown to modulate hippocampal place cells and LFPs. We
and others4-5 theorize that these landmarks and content shifts in rodent tasks act in a similar way to event
boundaries in human episodic memory. The proposed study introduces a novel experimental design to test two
candidate event boundaries in the rat, reward locations and task rule transitions paired to separately colored
sides of the maze. Aim 1 will focus on discerning how hippocampal place cells and theta sequences represent
space between pairs of reward locations and at environmental boundary transitions, and specifically how these
representations change upon introduction of new and conflicting reward locations. Aim 2 will focus on awake
SWR replays, also focusing on how segments between reward locations are represented and how these
representations are together integrated with newly introduced reward locations. Completion of this proposed
project will provide important insight into the neural mechanisms underlying episodic memory. This project will
provide rigorous practice in experimental and computational methods and will take place in Kamran Diba's
Neural Circuits and Memory lab as part of the Neuroscience Graduate Program at the University of Michigan.

Public health relevance
PROJECT NARRATIVE Our brains rely both on the segmentation of experience into distinct memories and on the integration of those episodic memories across space and time to inform our perception of the world and help us make decisions. Event boundaries are conceptual or physical boundaries such as reward locations or environment changes that can segment experience into distinct episodes. This project proposes a novel experimental design and set of analyses focused on illuminating how the hippocampus forms neural representations of segmented episodes through place cells, the firing of place-cell sequences during theta oscillations (“theta sequences”), and multi-neuronal replays during sharp-wave ripples, and how these representations and patterns are altered upon introduction of new event boundaries.